Liver disease impact on myeloid cells driving immunotherapy resistance in hepatocellular carcinoma

Project Summary/Abstract
Recent advances in the treatment of hepatocellular carcinoma (HCC) with immunotherapy have improved
therapeutic options for patients living with this cancer; however, many patients still do not benefit, and
response to immunotherapy regimens is complicated by underlying liver disease which exists simultaneously
with HCC. Dr. Keenan has designed and analyzed experiments uncovering mechanisms of resistance to
immunotherapy using single cell techniques in another primary liver cancer, specifically a population of
immunosuppressive myeloid cells (“CD14CTX”) that can induce immune paralysis in T cells. Her hypotheses are
that CD14CTX suppressive myeloid cells are enriched within non-virally-associated HCC, and that tyrosine
kinase inhibitors (TKI) which modulate myeloid cells can inhibit the suppressive functions of myeloid cells when
given in combination with checkpoint inhibitors (CPI). In Aim 1, she will use previously validated high-
dimensional single cell and in vitro assays to examine CD14CTX in viral and non-viral hepatitis. In Aim 2, she
will use spatial transcriptomics/proteomics and in vivo models to decipher spatial relationships within HCC
tumors by liver disease etiology. Finally in Aim 3, she will investigate the impact of CPI and TKI on myeloid cell
suppressive function using longitudinal patient samples and mechanistic assays. Dr. Keenan has outlined a
five-year career development plan to help her to achieve an independent lab-based research career as an
expert in liver immunobiology and cancer immunotherapy. To meet this goal, she has formed an Advisory
Committee of mentors with expertise in hepatobiliary malignancies and liver disease, single cell techniques
and computational immunology, and cancer immunotherapy, as well as abundant experience mentoring other
early career physician scientists. She has also assembled collaborators to provide their expertise in liver
immunobiology and tumor immunology, biostatistics, and single cell RNA and TCR sequencing analysis. Dr.
Keenan’s training plan objectives are to gain expertise in: 1) liver disease biology, 2) spatial transcriptomics
and proteomics, 3) translation to clinical trials. These will be accomplished through hands-on tutorials with
members of her advisory committee and collaborators, and from didactic courses in her protected time
provided by this training award. At the completion of this award, Dr. Keenan will have made substantial
progress to advance the field of cancer immunotherapy for patients with hepatocellular carcinoma and towards
her career development as a leader in the field of cancer immunology translational research.

Public health relevance
Project narrative Hepatocellular carcinoma (HCC) is a highly morbid cancer which arises in the background of liver inflammation and immune suppression which may limit the success of immunotherapy. We recently identified a novel mechanism of myeloid cells inducing immune paralysis in T cells in other primary liver tumors. The objective of the proposed research is to decipher the mechanism of myeloid cell immune suppression in relation to the underlying liver disease etiology in HCC, both in circulation and in tumors, and the impact of combination immunotherapy and tyrosine kinase inhibitors on myeloid cells.